TMEM106B and Mitochondrial Dysfunction in FTLD and Other Dementia

Dementia affects millions worldwide, yet remains without a cure, highlighting the urgent need for research into
its causes. Frontotemporal lobar degeneration (FTLD) is a significant contributor to middle-age-onset dementias,
accounting for up to 10% of cases and adding to the challenges faced by patients and caregivers. Genetic
variation at the TMEM106B locus has been identified as a risk factor for FTLD and other dementias, like
Alzheimer’s disease (AD). However, the specific mechanisms by which TMEM106B variants increase the risk of
developing these diseases remain unclear. The extensive documentation of mitochondrial dysfunction as a
feature of neurodegenerative diseases underscores its critical role in neuropathogenesis. Dysregulation of
mitochondria-associated endoplasmic reticulum membranes (MAMs), which play an important role in regulating
mitochondrial function, has been implicated in various neurodegenerative disorders. This dysregulation can lead
to impaired calcium signaling, disrupted lipid metabolism, and altered mitochondrial dynamics, ultimately
resulting in neuronal loss. Our ongoing research has uncovered a potential link between TMEM106B and
mitochondrial dysfunction. We have observed that elevated levels of TMEM106B are associated with changes
in mitochondrial morphology, reduced mitochondrial membrane potential, and impaired mitochondrial respiration
in HEK293 cells. Furthermore, we have found that TMEM106B is enriched in MAMs and interacts with Sigma 1
receptor (SigR1), a key protein involved in regulating MAM function. To further investigate the role of TMEM106B
in mitochondrial dysfunction and neuronal damage, we aim to determine if increased TMEM106B expression
leads to these outcomes in cultured cortical neurons. Additionally, we will explore the mechanisms underlying
TMEM106B-mediated mitochondrial dysfunction, focusing on its interaction with SigR1 and its impact on MAM
function. Understanding the relationship between TMEM106B and mitochondrial dysfunction could provide
valuable insights into the pathogenesis of FTLD and other related dementias. This knowledge could pave the
way for new therapeutic approaches aimed at addressing mitochondrial dysfunction in these debilitating
conditions.

Public health relevance
The proposed research aims to investigate the role of TMEM106B in mitochondrial function and its potential association with cognitive impairment in neurodegenerative diseases. By elucidating the molecular mechanisms underlying TMEM106B's impact on mitochondrial function, this study seeks to provide insights into the pathophysiology of aging-related cognitive decline and neurodegenerative disorders. The findings could lead to the identification of novel therapeutic targets for these conditions.